Biomaterials for Cardiac Regeneration

1 PROJECT SUMMARY (30 lines)
2
3 The objective of this proposal is to investigate the ability of an injectable polypeptide scaffold to
4 improve patient outcomes after myocardial infarction. This is motivated by the evidence that
5 cardiovascular disease is the leading cause of death in the world, with an estimated $127 billion
6 in healthcare costs annually in the United States. The pathologic remodeling induced by
7 cardiovascular disease, and specifically myocardial ischemia, can progress to heart failure in 1 in
8 3 patients, which may lead to devastating functional disability. The gold standard treatment for
9 myocardial ischemia is coronary artery bypass grafting (CABG) and percutaneous coronary
10 intervention (PCI). These modalities function by restoring blood flow to ischemic areas as
11 promptly as possible to limit the extent of the damage. However, they do nothing to address the
12 pathologic remodeling process that has already started to unfold with the initial insult. While PCI
13 and CABG are important to offset further functional decline, innovative treatment modalities are
14 needed to inhibit and reverse pathologic remodeling once it has already begun. Motivated by this
15 clear clinical need, we will investigate the applicability of partially ordered polypeptides (POPs) to
16 improve outcomes after myocardial infarction. POPs are a unique biomaterial that transition from
17 an injectable liquid at room temperature to a physically crosslinked, porous network at body
18 temperature. POPs are highly biocompatible, integrate into surrounding tissue, and initiate
19 remodeling, cell infiltration, and neovascularization. Further, their ability to phase transition at
20 body temperature allows for easy handling and integration in the operating room, as well as a
21 scalable manufacturing process that has the capability to be a clinically translatable product. Our
22 central goal will be to demonstrate that POPs are uniquely suited to provide the needed
23 mechanical support and well vascularized microenvironment essential for successful repair and
24 reversal of pathologic remodeling in cardiomyocytes. Our strategy will include tailoring POPs to
25 the correct porous microarchitecture and mechanical properties for their application in the heart.
26 We will then investigate the ability of POPs to augment outcomes following myocardial ischemia
27 in murine models of myocardial infarction. Functional and histological testing will be performed
28 and compared to controls. If this proposal is successful, it will provide an essential foundation to
29 commence large animal testing and translation into clinical settings. Therefore, the application of
30 POPs to this disease process has the potential to have a transformative impact on the lives of
31 patients who have undergone myocardial infarction by preserving cardiac function, and thus
32 reducing long term morbidity and mortality.

Public health relevance
PROJECT NARRATIVE (3 sentences) The objective of this proposal is to investigate the ability of an injectable polypeptide scaffold to preserve cardiac function after myocardial infarction. This is motivated by the evidence that cardiovascular disease is the leading cause of death in the world, with an estimated $127 billion in healthcare costs annually in the United States. While gold standard therapies – which focus on restoring blood flow to ischemic tissue – are an essential part of treating patients to prevent further damage, innovative treatment modalities are desperately needed to inhibit and reverse pathologic remodeling once it has already begun.